Integrating Radiologist Insights for Safe and Accurate AI-Assisted Prostate MRI Interpretation

Abstract: Advances in natural language processing can build on prior breakthroughs in image processing to
offer clinicians new AI tools in the fight against prostate cancer, the second leading cause of cancer death. Current
AI for interpreting multi­parametric MRI (mp­MRI) scans, the primary imaging modality in PCa, achieves high
performance through training on visual encodings of human expertise (e.g. lesion annotations). Such models fail
at translation to patient care because they do not derive and communicate their results through the standardized
format accepted by clinicians, PI­RADS. The expertise encoded in PI­RADS reports offers a major resource for
training AI to achieve clinical acceptance. The proposed research is needed to overcome two major gaps in
knowledge necessary to develop advanced AI systems that can learn from both visual (annotations) and text
(PI­RADS) exemplars. (1) Data availability: Public PCa data repositories provide mp­MRI scans and annotations
but omit accompanying PI­RADS reports. (2) AI modeling: Existing AI approaches focus on image processing
and lack the capacity to integrate complex radiologist expertise expressed through language. This study will test
the hypothesis that PI­RADS reports can be made machine­readable and combined with visual data so that AI
can be trained to interpret MRIs according to the reasoning processes of radiologists. Memorial Sloan Kettering
(MSK) radiologists and University of Delaware (UD) researchers will collaborate to achieve the following aims.
Aim 1): The MSK team will curate a comprehensive dataset by annotating 300 public and 50 MSK MRI scans with
corresponding PI­RADS reports. The UD team will leverage GPT­4 to automatically extract radiologists’ reasoning
processes, i.e., radiologist rationale, from each report. Aim 2): The UD team will develop a Prostate Vision­
Language Model (ProstateVLM), building on supportive pilot data to leverage medical foundation models and
successfully integrate both images (MRIs and annotations) and text (rationales) in a uniform embedding space.
ProstateVLM will be trained on the comprehensive dataset to accurately segment the prostate gland, anatomical
zones, and lesions on MRI scans and align its segmentation with radiologist expertise. Aim 3): The UD team will
evaluate whether inclusion of radiologist rationales from PI­RADS as training data improves MRI segmentation vs.
training on images alone, measured by Dice Score, mAP, etc. The MSK team will evaluate whether ProstateVLM’s
interpretations of MRIs align with those of radiologists, measured by a questionnaire scoring metrics for accuracy
and completeness. To support future research, the curated dataset and ProstateVLM will be shared through the
Cancer Imaging Archive (TCIA).

Public health relevance
Project Narrative: Artificial intelligence (AI) trained on large numbers of existing human generated image annotations can predict which regions of an MRI scan represent prostate cancer, but clinical acceptance is limited because results emerge from a “black box”. This study will test whether training on an additional large source of existing human expertise (text reports generated through the Prostate Imaging Reporting and Data System, PI RADS) can improve both the accuracy and interpretability of AI predictions of prostate cancer (PCa).